Scientific Information Management and Literature-Based Evaluations for the DTT - Support for External Peer Review

A number of complex scientific reports are prepared under this contract on the Report Development project. Coordination of peer review includes managing a directory of scientific experts, conflict of interest screening for reviewers and companies with potential financial interest, and compiling documents for internal DNTP record keeping. Peer reviews conducted under this project included Systematic Review on Fluoride, Technical Report TCPP, black cohosh, and triclosan, Toxicity Reports on soluble vanadium compounds, usnic acid, and usnea lichens, and Developmental and Reproductive Reports on Bisphenol AF.

Keywords: peer review